Support for the 7th Symposium on Harmful Algae in the US

This proposal is to support student and manager travel to the 7th Symposium on Harmful Algae in the United States. The symposium is intended to provide a forum for scientific exchange and technical communication on all aspects of HAB research in the United States and will cover a wide range of topics including HAB monitoring, event response, human health, toxins and toxin detection, fisheries and food webs, emerging technologies for detection, bloom ecology and dynamics, emerging issues, human dimensions, and communication, outreach, and education.

Public health relevance
7th Symposium on Harmful Algae in the United States- Public Health Relevance Harmful algal blooms are a public health concern nationwide in both our marine and fresh waters. In some HAB species, the human health impacts are well identified and require rigorous monitoring programs to assure public safety. In other HABs, the human health impacts are poorly understood and need further research to understand the populations at risk and the illness vectors.